A Point of Care Urine Test to Aid Diagnosis of Aspergillosis

Invasive aspergillosis (IA) was recently named by the WHO as an infection causing “critical”
threats to public health, with unmet needs in both diagnostics and therapeutics. Leveraging
novel discoveries supporting patent-protected and proprietary technology that enables
identification of microbial antigens in urine, Pearl Diagnostics (PearlDx) has developed the first
urine assay for IA, formatted as a high-volume enzyme immunoassay (EIA) that is CE marked
and under review for clearance at the FDA. PearlDx has also developed a lateral flow device
(LFD) that will enable easier, point of care (POC) testing in small hospital labs and clinics. Using
support from prior Phase I and II STTR grants, we characterized heterogeneous urinary
antigens, and developed methods to combine glycan-specific antibodies and eliminate biologic
interferents in urine. Like the EIA, the LFD currently demonstrates 90% sensitivity and
specificity, improving on performance of the current blood-based commercial assay and
exceeding FDA pre-510k agreed upon metrics for regulatory clearance. To enable use at POC,
we now enter the last stage of optimization, which is focused on eliminating the need for a lab to
perform sample processing. This commercial readiness pilot proposal supports final integration
and clinical testing for FDA clearance of the LFD. Success in meeting the milestones described
will lead to commercial availability of the first rapid, easy to use urine diagnostic for IA, enabling
earlier detection and therapy of this critical infectious disease threat.

Public health relevance
Invasive aspergillosis is a lung infection caused by the inhalation of fungal spores that are present everywhere in our environment. People with weakened immune systems caused by treatment of cancer and/or transplantation, and people with severe lung diseases associated with smoking and severe respiratory viruses are at a high risk of developing this infection. The infection is hard to diagnose and frequently requires insertion of a tube into the lungs to recover fluids; we have developed a rapid, easy to use urine test to detect the fungus in the body, which will be useful to direct early therapy.